Elucidating the Sensorial and Functional Characteristics of Compositionally Different and Differently Aged Topical Formulations

Abstract
The focus of this application is, to understand the impact of compositional differences in topical
formulations, on their physical and structural attributes, and in turn, on a patient's perception,
which may be linked to therapeutic effect. Additionally, the impact of product ageing on critical
Q3 attributes that may in turn affect perception will be investigated through sensorial trials.
Prior to this renewal opportunity, we have manufactured 26 gels with different amounts of HEC
and CBP used a polymeric gelling agents. Further Q2 differences were introduced by varying
propylene glycol and alcohol content, systematically. These products were extensively
characterized for a range of Q3 parameters that relate to key sensorial perceptions. As a part
of this project renewal, we will start sensorial focus group evaluations. We have been
successful at gaining ethics approval from our local IRB and a non-involvement status from
FDA, in readiness for the trials. An additional new dimension included in this renewal is, testing
the product quality/structural attributes as well as sensory attributes on different topical
products at predetermined time points during a product’s shelf life. We have developed
instrumental techniques with robustly designed methods as a part of our current work, which
can be used to predict patient perception/acceptance. These tests once compared against
sensory panel test and validated could potentially replace sensory panel testing. This would
be immensely beneficial to the industry.

Public health relevance
Narrative Regulatory authorities around the world have been making efforts to move away from clinical bioequivalence study to prove equivalent performance between a generic and a reference listed drug product. Similar efforts are required in moving away from using volunteers for sensorial panel tests. A CQAs and Q3 based approach can be successful in estimating sensorial equivalence, just as the characterisation-based approach has been successful at mitigating failure modes in therapeutic equivalence and bioequivalence.